SSFP Cardiovascular MR Imaging on 3.0T Using Unified-Coil Local Shimming

Abstract
Cardiovascular disease is the leading cause of death globally. Cardiovascular magnetic resonance (CMR)
is routinely used in the clinical management of cardiovascular disease and is the standard method for the
assessment of cardiac function and myocardial tissue properties. Today, most clinical CMR studies are still
conducted on 1.5T scanners because of their availability and robustness in executing CMR protocols. In
general, 3.0T provides higher SNR, spatial resolution, and reduced scan time than 1.5T. However, the
increased B0 field strength also poses technical challenges for CMR. A major challenge is the susceptibility or
off-resonance artifacts due to worsened B0 field inhomogeneity.
In the last two decades, steady-state free precession (SSFP) has revolutionized CMR on 1.5T because it
boosts SNR and contrast to noise ratio (CNR) markedly over gradient-echo based acquisitions. However, its
routine use on 3.0T has been inconsistent despite continuously improving B0 homogeneity and shimming
capabilities. Therefore, gradient-echo based acquisitions are still routinely used, such as for cine imaging,
cardiac relaxometry, and coronary MRA, negating the major advantages of 3.0T for CMR. Due to the distance
of standard whole-body shimming coils from the target organ, they only provide shimming capabilities up to the
second-order spherical harmonic (SH), and are incapable of shimming higher-order localized field variations
such as those present near the heart-lung interface. This remains an unmet challenge.
In this project, we will apply a novel unified shim-RF coil technique to overcome the primary limitation in
3.0T CMR. We will develop a unified shim-RF coil and validate its safety and high-order shimming capability
(Aim 1). We will develop a respiratory motion-resolved B0 field mapping technique based on our low-rank
Multitasking framework and real-time shim circuits to allow dynamic shimming for free breathing CMR (Aim 2).
We will then validate the technology in human subjects on 3.0T (Aim 3). Successful completion of this project
will enable robust SSFP CMR on 3.0T, a major technical challenge, which allows reliable high-resolution, high-
SNR CMR, including but not limited to cine and coronary MRA. This novel cardiac shimming system has the
potential to have a major impact in accelerating the clinical adoption of 3.0T CMR.

Public health relevance
Project Narrative Cardiovascular magnetic resonance imaging (CMR) is routinely used in the clinical management of cardiovascular disease and is the standard method for the assessment of cardiac function and myocardial tissue properties. However, B0 inhomogeneity represents the biggest challenge for clinical CMR on 3.0T because it prevents the consistent application of steady-state free precession (SSFP), which revolutionized CMR at 1.5T. This project will apply a novel unified shim-RF coil technique to overcome the primary limitation and enable robust SSFP CMR on 3.0T, which has the potential to have a major impact in accelerating the clinical adoption of 3.0T CMR.